Dynamic Decision Support Tools for Precision Treatment-Resistant Depression Care

Depressed patients who fail to respond to >2 antidepressants are burdened by treatment-resistant depression
(TRD) and endure lengthy trial-and-error attempts on multiple treatment regimes while at risk for poor outcomes.
Clinicians lack decision support tools to select initial or subsequent TRD treatments in part because predictors
of treatment response are considered static (time-fixed), despite varying over time. Clinical decision support
systems (CDSS) called for in MH-25-190 need dynamic treatment regimes (DTRs): sequences of rules
that dynamically update response predictions as information accumulates. We will achieve this with:
1. Electronic Health, Patient-Reported Outcome, and Digital Biomarker Data on >10,000 TRD Patients Annually;
2. Advanced Causal Inference and Target Trial Emulation to Control for Time-Varying Confounding; and a
3. Sequential Multiple Assignment Randomized Trial (SMART) to Optimize Dynamic Decision Support Rules in:
Aim 1. Pipeline to Identify Dynamic Treatment Regimes (DTRs) for Clinical Decision Support Systems
TRD regimes received by >10,000 TRD outpatients in >85,000 visits annually, will include: medication
management (e.g., combining, switching, or augmenting antidepressants); rTMS; psychotherapies; and
esketamine or ketamine. We will create a pipeline to: a) generate features from electronic health, patient-reported
outcome, and raw digital biomarker data; b) filter features; c) control for time-varying confounding with advanced
causal inference; d) evaluate dynamic prediction rules to classify patients according to treatments they are likely
to benefit from; and e) empirically design a CDSS with optimal DTRs for TRD.
Aim 2. Target Trial Emulation (TTE) of the Clinical Decision Support System (CDSS) for TRD
Although milestones (e.g., AUROC> .8) will be used to analytically validate models in Aim 1, they cannot estimate
clinical benefits of using a CDSS to select treatments v. usual trial-and-error care. Before committing to a
randomized trial, target trial emulation (TTE) is a gold standard way to first use observational data to evaluate
comparative effectiveness. We will employ TTE to compare using DTRs in a CDSS to select TRD treatments v.
usual trial-and-error care; milestones from our TTE (e.g., Cohen’s d for CDSS-informed care >.5) will determine
if we proceed with user-centered design of a CDSS and testing in the randomized effectiveness trial in Aim 3.
Aim 3. Effectiveness Trial of Clinical Decision Support System (CDSS)-Informed vs. Usual TRD Care
We will conduct an effectiveness trial in which 1,000 TRD patients are randomized to a CDSS with optimal
DTRs from a SMART v. usual trial-and-error care. On-line (live and in real-time) reinforcement learning models
will use past and current tailoring variables to predict an individual’s response to treatments in the next interval,
and also adapt based upon prior participants’ responses. We will compare both arms on distal outcomes (i.e.,
ER visits or hospitalizations for depression; all-cause and suicide deaths), and work with NIMH/FDA to ensure
the trial serves as a “Real-World Performance” review for FDA Software as a Medical Device designation.

Public health relevance
NARRATIVE Despite being at risk for adverse outcomes, patients with treatment-resistant depression (TRD) endure lengthy trial-and-error attempts on multiple evidence-based treatment regimes, including: medication management (i.e., combining, augmenting, or switching antidepressants); repetitive transcranial magnetic stimulation; psychotherapies; and esketamine/ketamine. Clinicians need decision support tools called for in MH-25-190 to select initial and subsequent TRD treatments, that dynamically update treatment response predictions as information on a patient accumulates. We will use electronic health, patient-reported outcome, and digital biomarker data on >10,000 TRD patients annually to: develop and evaluate the clinical benefits of using a clinical decision support system (CDSS) to select optimal TRD treatments; and test using this CDSS to select treatments vs. usual trial and error TRD care in a randomized effectiveness trial involving 1,000 TRD patients nationally.